fMRI Studies of Neural Dysfunction in Autistic Toddlers

[unreadable] DESCRIPTION (provided by applicant): The behavioral and cognitive deficits of autism are underpinned by both structural and functional maldevelopment in the young brain. While structural abnormalities in the first few years of life have been studied, producing a wealth of information and new theories about the disorder, functional abnormalities have thus far been relatively unexplored due to the expected difficulties in imaging such a young age cohort. Preliminary work completed by this laboratory, however, demonstrates that it is possible to use sleep fMRI to study brain function in both autistic and typically developing toddlers. The results obtained thus far are consonant with both structural studies of the young brain and functional studies in older autistic subjects. In autistic toddlers hearing neutral speech, higher-order cortices display aberrant lateralization and unusual activation patterns that are similar to far younger typical toddlers, with abnormalities particularly marked in frontal, temporal and cerebellar cortices. Our cross-sectional studies of typical toddlers, meanwhile, suggest increased specialization of speech processing with a developmental shift from activation of bilateral frontal, temporal and cerebellar regions in 20 month olds to temporal cortex and right cerebellum by 3 years of age. We also show the feasibility of conducting fMRI studies of social and non-social orienting sounds in toddlers. We will conduct fMRI studies of the 30-month-old autistic toddler's neural responses to social and non- social; emotional and emotionally-neutral; and speech and non-speech sounds, as well as to basic visual stimuli. Our comparison groups will be mental age matched (18-month-old) and chronological age matched (30-month-old) typically developing toddlers. Each typically developing child will be imaged at both ages; this longitudinal design will allow us to also explore typical functional development, itself a nascent field of knowledge. Our functional findings will be correlated with behavioral, anatomical, developmental, and clinical data so as to assemble a picture of the complex interactions between brain structure, brain function, developmental trajectory, and behavior in both the autistic and typically developing brain. These pioneering studies will be among the first to pinpoint functional deficits in the autistic brain as close as possible to the onset of clinical symptoms, with implications for new models of the disorder, further study of its biological basis, the search for early diagnostic markers, and the development of novel therapies. [unreadable] [unreadable] [unreadable]